Functional Organization of the Central Gustatory System

DESCRIPTION (provided by applicant): Injury to structures in the central gustatory system such as the insula and operculum, the site of primary gustatory cortex in humans, can alter the flow of ascending and descending taste-related information through the brain which has great potential to disrupt normal gustatory processing and can have detrimental consequences on health and quality of life. As more advances are made in discerning the pharmacology, connectivity, and physiological phenotype of taste-responsive neurons in the brain, it is becoming increasingly critical for the field to develop and apply appropriate behavioral assays in animal models to explicitly link neurobiological processes to taste function. There is evidence in the literature that patients with damage involving primary gustatory cortex display hypogeusia and have difficulty identifying and recognizing tastes. In rats, lesions in the gustatory cortex retard, but do not eliminate, the acquisition of a conditioned taste aversion, retard acquisition of taste-based anticipatory contrast, and impair the expression of taste neophobia. In contrast, these lesions cause little, if any, effect on unconditioned taste preference and avoidance and do not disrupt taste preference conditioning. The prevailing view in the literature is that animals with gustatory cortex lesions display normal taste detection and discriminability, but, in actuality, this remains to be explicitly tested. Virtually all of the experiments on the effects of gustatory cortex lesions in rats have involved assessment of either conditioned or unconditioned affective/hedonic responsiveness to taste compounds. Moreover, with few exceptions, taste palatability has been assessed with intake and preference tests, which can be heavily influenced by postingestive factors and provide only a partial analysis of affective responsiveness. Thus, conclusions regarding the functional role of gustatory cortex are based on a relatively constrained set of behavioral observations. The goal of the proposed series of experiments is to fill this interpretive void by explicitly testing the necessity of the gustatory cortex in the maintenance of sensory-discriminative vs. affective taste function. Using a technically sophisticated apparatus (gustometer), we plan to test rats with and without ibotenic acid-induced lesions in the gustatory cortex in a variety of behavioral tasks designed to measure taste sensitivity (Exp. 1), taste quality discrimination (Exp.2 & 3), the qualitative specificity of conditioned taste aversions (Exp. 3), and unconditioned affective responsiveness to taste stimuli as assessed by brief access licking tests (Exp. 4) and oromotor taste reactivity (Exp. 5). We predict that these lesions will blunt sensitivity and compromise the animal's ability to discriminate among taste stimuli that are used as sensory signals in psychophysical tasks, without affecting the palatability of the compounds. Regardless of the specific outcomes of these experiments, the data generated should provide a functional context in which to understand central gustatory processing.

Public health relevance
PUBLIC HEALTH RELEVANCE: Impairments in the sense of taste can be very debilitating, adversely affecting the quality of life in such patients and jeopardizing their health. Moreover, given the role of taste in feeding and drinking, damage to the gustatory system can potentially contribute to more complex clinical disorders involving nutritional status, hydromineral balance, and obesity. The development of animal models, in which the gustatory system can be experimentally manipulated and the perceptual consequences assessed, is essential to gain an understanding of the underlying neurobiology of normal and abnormal taste function - a first step in refining the clinical management of patients suffering damage to gustatory brain sites and potentially leading to the development of therapeutic interventions. PROGRAM NARATIVE Impairments in the sense of taste can be very debilitating, adversely affecting the quality of life in such patients and jeopardizing their health. Moreover, given the role of taste in feeding and drinking, damage to the gustatory system can potentially contribute to more complex clinical disorders involving nutritional status, hydromineral balance, and obesity. The development of animal models, in which the gustatory system can be experimentally manipulated and the perceptual consequences assessed, is essential to gain an understanding of the underlying neurobiology of normal and abnormal taste function - a first step in refining the clinical management of patients suffering damage to gustatory brain sites and potentially leading to the development of therapeutic interventions. __SpecificAimsTextDelimiter__ I. SPECIFIC AIMS Relative to other sensory modalities, such as vision and audition, the analysis of the functional organization of the central gustatory system remains in its infancy. As more advances are made in discerning the pharmacology, connectivity, and physiological phenotype of taste-responsive neurons in the brain, it is becoming increasingly critical for the field to develop and apply appropriate behavioral assays in animal models to explicitly link neurobiological processes to taste function. Along these lines, the long term objective of the project proposed here is to characterize the functional roles of gustatory circuits in the brain by producing selective lesions in strategic locations along the central gustatory pathways, thus altering the flow of ascending and descending taste-related signals, and then assessing the behavioral consequences. The findings from such experiments should guide molecular, anatomical, pharmacological, and electrophysiological analyses of various populations of taste-responsive neurons and provide a functional context to help inform interpretation. We have chosen to start this effort by focusing on the role of gustatory cortex in taste function. In terms of information flow, the gustatory cortex can be considered, in some sense, the cardinal structure in one of the two diverging forebrain branches of the rodent ascending gustatory system. Pfaffmann and colleagues (113) speculated some years ago that the thalamocortical pathway arising from the gustatory zone of the parabrachial nucleus (PBN) was associated with sensory-discriminative function, whereas the ventral forebrain pathway from the PBN was associated with taste hedonics. The role of the ventral forebrain in taste affect enjoys some published support, but the contribution of the thalamocortical pathway to sensory- discriminative taste function has eluded confirmation. Although somewhat fragmentary, there is evidence in the literature that patients with cortical damage involving the insula and operculum, the sites of primary gustatory cortex in humans, display hypogeusias and have difficulty identifying and recognizing tastes (22; 85; 114; 115; 132; 133; 172). In rats, lesions in the gustatory cortex retard, but do not eliminate, the acquisition of a conditioned taste aversion (10; 15-17; 26; 30; 36; 62; 64; 76; 95; 118; 119; 125; 174; 183; 184), retard acquisition of taste-based anticipatory contrast (61; 177), and impair the expression of taste neophobia (30; 69; 119; 183; 184). In contrast, these lesions cause little, if any, effect on unconditioned taste preference and avoidance (16), and do not disrupt taste preference conditioning (159). The prevailing view in the literature is that animals with gustatory cortex lesions display normal taste detection and discriminability, but, in actuality, this remains to be explicitly tested. Virtually all of the experiments on the effects of gustatory cortex lesions in rats have involved assessment of either conditioned or unconditioned affective/hedonic responsiveness to taste compounds. Moreover, with few exceptions (26; 64; 125), taste palatability has been assessed with intake and preference tests, which can be heavily influenced by postingestive factors and provide only a partial analysis of affective responsiveness. Thus, conclusions regarding the functional role of gustatory cortex are based on a relatively constrained set of behavioral observations. The proposed series of experiments seeks to fill this interpretive void by explicitly testing, in a rat model, the overarching hypothesis that the gustatory cortex is necessary for the maintenance of normal sensory- discriminative taste function, but is not necessary for normal conditioned or unconditioned hedonic responsiveness to taste compounds to be expressed. Specific Aim 1: Apply a taste signal detection task to test the hypothesis that gustatory cortex lesions decrease taste sensitivity to prototypical taste compounds. Specific Aim 2: Apply a taste signal discrimination task to test the hypothesis that gustatory cortex lesions severely impair taste quality discrimination and recognition. Specific Aim 3: Test the hypothesis that gustatory cortex lesions do not compromise the ability to form conditioned changes in palatability to specific taste stimuli. Specific Aim 4: Test the hypothesis that gustatory cortex lesions do not impair a rat's hedonic responsiveness to prototypical taste compounds even when assessed by behavioral procedures that minimize postingestive influences.